Building capacity for Global Infectious Disease Research Training in Schistosomiasis in sub-Saharan Africa

Program abstract
This is an application for a two-year planning grant to build capacity for an international advanced research
training in schistosomiasis in Uganda. The high burden of schistosomiasis in Uganda persists since the
1950’s Over 50% of the Ugandan population is at risk of exposure to Schistosoma species and its
complications of fatal upper gastro-intestinal bleeding among adults. Gaps in control of schistosomiasis
remain due to limited number of scientists with capacity to conduct advanced research and training focused
on schistosomiasis epidemiology, vector biology, immunology, vaccinology, therapeutics, genomics,
computational biology to model the schistosomiasis transmission, data science and artificial intelligence to
model population behavior and other predictors of disease severity, as well as local development and
production of effective vaccine candidates, and the application of locally generated data to inform relevant
interventions for disease surveillance and control interventions in the affected communities. We propose to
conduct a comprehensive needs assessment of the existing research and training capacity for
schistosomiasis at Makerere University College of Health Sciences (MakCHS) and the collaborating
institutions in Uganda (Uganda Virus Research Institute-UVRI, the Ministry of Vector Control Division in
charge of schistosomiasis and other medical schools in the country). Findings from the needs assessment
will be used to develop of an innovative research training and career enhancement program to strengthen
capacity of scientists and health research professionals to conduct independent, multi-disciplinary research
in schistosomiasis. During the two-year planning period we will hold multiple stakeholder engagements and
identify the research training resources, local and international faculty, scientific environment contributions
and administrative processes needed to undertake a schistosomiasis research training program. We will
establish a strong executive committee to oversee the design and preparation of advanced scientific didactic
and methodology courses (physical and virtual) and research training resources for schistosomiasis
epidemiology, disease management, prevention, and control. We will also establish an international multi-
disciplinary training advisory committee that will meet quarterly to guide and monitor the progress of the
planning process against the set goals and milestones. The proposed planning grant will build on existing
infection and immunity research training partnerships between MakCHS and UVRI, and long-standing
research training collaborations with our US partners (John Hopkins University and University of Washington).
We will reach out for new collaborations that may be required locally and abroad to establish a wholistic,
multi-disciplinary network of scientists with an effective organizational structure that will support the
envisioned research training program, and resultant collaborative five-year training program (D43) application
for better control schistosomiasis in Uganda.
1

Public health relevance
Program narrative Africa bears direct morbidity and mortality from poverty-related and neglected tropical diseases including schistosomiasis, which remains endemic in Uganda with an estimated 50% of the population at risk of infection and the associated complications of portal hypertension and fatal upper gastro- intestinal bleeding. Since the description of schistosomiasis in Uganda in the 1950s, efforts to control schistosomiasis remain limited due to incomplete understanding of the pathogen, disease manifestations and transmission mechanisms, and inadequate preventive measures and interventions. Capacity for advanced research training is clearly needed provide schistosomiasis-focused scientists with sufficient capacity to analyze, model and predict relevant clinical case management systems, biological interventions, and disease control efforts in Uganda. 1